A Shared Decision-Making Tool to Support Emergency Department Dispositions for Veterans with Dementia

It is currently estimated that 10% of the Veteran population aged ≥65 years has Alzheimer’s disease or Alz-
heimer’s disease related dementias (AD/ADRD), and this number is expected to increase by 22% in the next
decade. The Emergency Department (ED) is an essential care setting for these persons living with dementia
(PLWDs), with 40% of community-dwelling PLWDs making at least one ED visit per year. One of the most im-
pactful and costly elements of ED care is the decision to admit a patient to the hospital or discharge them home-
the “disposition” decision. ED providers must balance the risks of unnecessary admissions, such as delirium and
functional decline, against the risks of discharge, which may result in return ED visits and hospitalizations. The
disposition decision is difficult when the need for hospitalization for further testing or monitoring is unclear. It can
also be especially challenging with PLWDs, as they can have difficulties in providing accurate histories to guide
ED testing and diagnosis. There is significant variation in ED disposition practices, driven by factors including
patient sociodemographics and comorbidities, as well as physician risk tolerance. ED providers lack best prac-
tices to incorporate PLWD and caregiver values and preferences in the disposition decision when there is no
serious illness that clearly requires admission. Shared decision making (SDM) tools can facilitate complex con-
versations between patients, caregivers, and ED providers, to ensure that patients and caregivers are meaning-
fully involved in decisions about their care. The research proposed in this application is designed to develop a
shared decision making tool to support ED dispositions that are aligned with PLWD and caregiver goals, and
thereby improve outcomes for Veteran PLWDs and their caregivers.
With the support of her mentorship team, this proposal is also intended to support the continued career devel-
opment of Dr. Justine Seidenfeld, an extremely promising emergency medicine physician-scientist, within the
field of emergency care health services research. During this period of support, she will pursue didactic instruc-
tion and further training to 1) advance her skills in methods for conducting research with PLWDs and their
caregivers, 2) learn best practices to design and implement interventions aligned with end-user needs, and 3)
develop skills for development and testing of SDM tools. The expected outcome of this proposal is to construct
and pilot test a SDM tool to support high-quality ED dispositions for PLWDs. Along with mentored training, this
will position her to submit a competitive Investigator Initiated Research (IIR) application to test its effectiveness
in a fully powered trial. Her long-term career objective is to become an independent health services researcher,
skilled in using diverse methods to promote high-quality ED care for Veterans with dementia.
This study employs a sequential design based on the 3-step decision aid development process created by the
International Patient Decision Aid Standards (IPDAS) collaboration. Aims 1 and 2 will address the first “under-
stand user” step through quantitative and qualitative methods. Aim 1 will calculate home time (i.e., days alive
and out of acute and post-acute settings) after an ED visit for a cohort of Veterans with dementia, and identify
Veteran, ED facility, and visit type characteristics that are associated with variation in home time to suggest
groups that may benefit from a customized SDM tool. Aim 2 will use qualitative interviews with Veteran PLWDs,
their caregivers, and ED providers after an ED visit to assess their unmet needs, values, and preferences when
making a disposition decision. To fulfill the “development/refinement” and “assessment” steps of the IPDAS de-
velopment process, Aim 3a will create and iteratively refine a prototype SDM tool with feedback from a multidis-
ciplinary collaborator panel, and Aim 3b will then use a iterative cohort pilot study design to assess the feasibility
and acceptability among PLWDs, caregivers, and ED providers.

Public health relevance
Veterans living with dementia and their caregivers frequently visit the Emergency Department (ED), so it is es- sential that they be able to make informed decisions about their care. One of the most critical choices during an ED visit is the decision to be admitted to the hospital or to be discharged home. This decision is especially difficult when ED testing has not found a clear reason for admission, and the need for hospitalization for further testing or monitoring is unclear. However, there are significant risks associated with either choice, such as hospital- acquired infections when admitted, or return ED visits when discharged. This research project seeks to develop a shared decision making tool that will help Veterans living with dementia, their caregivers, and ED health care providers have conversations about risks, benefits and what matters most, in order to make a disposition decision that is aligned with patient and caregiver values and preferences. This work will ultimately improve the delivery of high-quality ED care for Veterans with dementia and their caregivers.